ANABOLIC EFFECT OF GROWTH HORMONE AND EXERCISE IN YOUNG AND ELDERLY MALES

The effects of heavy resistance exercise and growth hormone administration (alone and in combination) on skeletal muscle and whole-body protein metabolism will be studied using stable-isotope labelled tracers and muscle biopsies in young and elderly subjects.